Dashboards promoting antimicrobial stewardship in a veterinary teaching hospital

1 Project Summary: Veterinary teaching hospitals are important tertiary care centers for high-
2 quality, cutting-edge care of animals. As veterinary medicine has evolved to resemble human
3 medicine in complexity, it has become apparent that complications historically observed in
4 human medicine are now of consequence in veterinary medicine and efforts are needed at the
5 hospital level to reduce harm. Antimicrobial resistance (AMR) is a critical human health
6 challenge and is reported more frequently in veterinary medicine. Not only do resistant bacterial
7 infections impact animal health and welfare, but they also have potential to cause negative
8 human health consequences through transmission of resistant bacteria or resistance genes
9 through animal contact or the shared environment. Little information is available to assess
10 impact of AMR bacterial infections in veterinary medicine, but presumably there is a significant
11 cost both in morbidity and mortality, economic output for treatment, lost productivity in animal
12 agriculture and emotional distress of animal owners and caregivers. In order to understand and
13 mitigate infections from antimicrobial resistant bacteria in a veterinary teaching hospital, the
14 collection of data related to patient outcomes, antimicrobial use and bacterial characterization,
15 including whole genome sequencing, must be performed. While obtaining data is a primary step,
16 data management, visualization and analysis is must be built to ensure data can be useful for
17 stakeholders in teaching hospitals, including faculty clinicians, trainees, students and staff. Data
18 dashboards provide this tool to tailor information that is accessible for users with varying skill in
19 data analytics. Dashboards can be configured to provide pertinent information on individual
20 providers, service and hospital wide antimicrobial use, rates of surgical site infections,
21 antimicrobial susceptibility test patterns, rates of resistant bacteria and results of environmental
22 surveillance of resistant bacteria. The purpose of this proposal is to create user-friendly data
23 dashboards for multiple metrics for the Washington State University College of Veterinary
24 Medicine Teaching Hospital for use in antimicrobial stewardship and infection prevention and
25 control efforts and education. Additionally, these dashboards could be shared with other
26 Veterinary Teaching Hospitals.
27
28

Public health relevance
Project Narrative: Antimicrobial use, bacterial resistance monitoring and surgical site infection rates are critical data needed in veterinary hospitals to promote antimicrobial stewardship and contribute to infection control and prevention. Leveraging this data for the development of visualization dashboards can facilitate data analysis and be used as educational tools for hospital administrators, clinicians, technicians and students. Ultimately, better tracking of antimicrobial use, resistant bacteria and surgical site infections can support data-driven practice change and education around antimicrobial use and infection prevention and control in veterinary teaching hospitals.